HERPESVIRUS INFECTIONS AND NERVOUS SYSTEM DISEASES

This project seeks to define the spectrum of acute, latent and recurrent CNS and PNS disease produced by experimental herpesvirus infections, particularly herpes simplex virus 2 (HSV-2), and to refine and test a hypothesis which relate HSV-2 infection to human demyelinative disease, including multiple sclerosis (MS). Our previous studies suggest that several features of HSV epidemiology and pathology are consistent with a possible etiological role for this agent in MS. During FY 1988, studies performed show that HSV-related antigen previously found in human demyelinative lesions does not appear to be related to human cytomegalovirus or varicella-zoster virus. Efforts were begun to more precisely identify the antigen detected and to provide independent evidence of virus presence in lesions. In experimental models, reactivated HSV-2 infection has been induced using high-dose immunosuppression. Targets of reactivated infection in mice with latent infection established by intracerebral inoculation of virus include CNS and PNS tissues, as well as a variety of peripheral, non-neural tissues. This is the first animal model in which the CNS is shown to be an important target of reactivated HSV infection.